CORE--ANIMAL FACILITY

This core provides in vivo model support for the three research projects. Specifically: 1. Support for Projects 1 and 2: Tumor growth delay studies will be carried out in male nude mice bering subcutaneously implanted human prostate carcinoma (PC-3, DU-145, LnCaP or CWR22) or human bladder carcinoma (RT4 or 5637). The animals will be treated with local hyperthermia to the tumor-bearing limb via water bath heating in the presence or absence of thermal sensitizer administration and/or fractionated radiation therapy (daily for 5 days by external beam). The results of these studies will provide an indication of therapeutic efficacy for the findings of Project 2 and provide a basis for translation of potential thermal sensitizes into Project 1. 2. Support for Projects 1 and 3: Large animals (pigs) will be used as a preclinical in vivo system to test the characteristics of new insonation portals using FSUM spherical applicator and urethral thermometry techniques. These animals will be fully instrumented for acquisition and analysis of all temperature and perfusion data, thus allowing calculation of ultrasound power fields, temperature fields, and thermal dose data. The results of these studies will translate into continued instrument development in Project 3 and into clinical protocol development in Project 1.